Diabetes Research Center (DRC)

The overall mission of the UCSD/UCLA DRC centers on supporting research in the prevention and treatment
of diabetes and its complications to ultimately improve the lives of patients. For the past 22 years, our DRC has
been unique in linking together the diabetes/metabolism research activities of two major universities within
the UC system and their affiliated institutions in Southern California. This effort has fostered new
collaborations and interactions between outstanding scientists within and across these institutions. Our
research base is comprised of the following focus areas: Integrative Physiology, Cell Signaling and
Transcriptional Regulation, Genetics and Genomics, Translational Sciences and Complications. Each of these
areas has outstanding leaders who facilitate interactions and sharing of resources. The DRC has played an
important role in promoting the careers of young scientists as they move to the status of independent
investigators by awarding pilot and feasibility grants. As an acknowledgement of our success in this effort,
UCSD and UCLA have agreed to provide $100,000/year in additional unrestricted funds to augment our P&F
program. The DRC will continue to advance scientific and intellectual interactions by organizing and
facilitating meetings, lectures, and mentoring efforts that are part of our Enrichment Program, and we
continue to pay special attention to including diverse viewpoints and experiences. We will further accelerate
diabetes research at the DRC Institutions by providing state-of-the-art services through five cutting edge cores:
A) The Transgenic and CRISPR Mouse Core, B) Metabolic and Molecular Physiology Core, C) Epigenetics and
Genomics Core, D) Human Genetics Core, and E) Biological Imaging Core. All our research cores have been
updated with new services and the latest technologies in response to the needs of our faculty and the many
advances in this field as they relate to diabetes and metabolism research. Our efforts to support the cores and
facilitate collaboration have been successful, as can be judged by the numerous collaborative publications in
high impact journals and the substantial peer review grant support our faculty have accrued. The current
competitive renewal application includes many new scientific and technological advancements, including the
incorporation of new services that are now available to our members in a streamlined fashion. Our future plans
include the continued seamless integration of research at all participating institutions to enhance technology
and research capability within the DRC, with the addition of a new cadre of affiliated investigators at
neighboring institutions. We will continue to promote the careers of promising young investigators through our
successful P&F Program, and to accelerate translational research activity and collaborations through
interactions with the CTSA programs at both institutions and beyond.

Public health relevance
Project narrative The UCSD/UCLA DRC will enhance research into the etiology, pathophysiology, treatment, and prevention of diabetes and its complications through facilitation of scientific exchange, and advancement of the outstanding scientific faculty comprising our research base, by providing access to novel biomedical research cores and promoting the careers of young scientists. This will ultimately improve the lives of patients with diabetes, who will benefit from the advancements the center will generate.